Defining the Role of Renal Gluconeogenesis in Renal Cell Carcinoma

PROJECT SUMMARY
Renal cell carcinoma is the most common primary kidney cancer, representing 90-95% of primary renal
neoplasms. Our work in the parent award has identified a novel liver-brain-adipose tissue-kidney
gluconeogenesis axis that drives renal cell carcinoma, driven by fibroblast growth factor (FGF)-21. While
completing studies in the parent award, we became aware that our murine models of RCC exhibit cancer
cachexia, with striking loss of skeletal muscle. Cancer cachexia is a widespread and debilitating problem, and
the work proposed in this supplement will test the hypothesis that FGF-21-driven renal gluconeogenesis
may be a key contributor to cachexia in renal cell carcinoma. The candidate, Andin Fosam, is an African
American, first generation American citizen who aims to become a physician-scientist leading a translational
research program at the intersection between oncology and preservation of functional status. The work
proposed in this supplement application will position Andin, an M.D./Ph.D. student completing her doctoral
work in the PI's lab, as a growing leader in this multifaceted area, which is in deep need of new investigators to
push the boundaries of our understanding of how physiologic principles can help avoid the devastating
consequences of cancer cachexia.

Public health relevance
PROJECT NARRATIVE Our laboratory has identified a new mechanism by which crosstalk between liver, brain, fat tissue, and kidney drives the most common form of kidney cancer, renal cell carcinoma. We have also observed that mice lose muscle mass as they develop renal cell carcinoma tumors, in a process called cancer cachexia. Work proposed in this supplement will ascertain how, and will support the work of the candidate, Andin Fosam, a rising star in the areas of muscle function, health maintenance, and cancer.